Molecular mechanisms underlying cortical interneuron synaptic specificity

Project Summary/Abstract
Cortical inhibitory GABAergic interneurons (INs), which develop intricate local circuits, critically regulate higher-
order brain functions by balancing and shaping neuronal activity. Consistent with its indispensable role in
normal brain functions, malformation/malfunction of the inhibitory system is implicated in a wide array of brain
disorders such as schizophrenia, autism, and epilepsy. Despite their importance, the molecular mechanisms
underlying the wiring of IN local circuits remain largely unknown. Cortical INs comprise diverse cell types that
are defined by morphology, physiology, and gene expression. Notably, different IN subtypes also show distinct
synaptic specificity at laminar/cellular as well as subcellular levels. Although subtype-specific synaptic
connectivity is considered a critical property of INs to ensure functional diversity of the inhibitory system, the
molecular mechanisms underlying IN synaptic specificity remains poorly understood. The objective of this
proposal is to determine the molecular mechanisms by which IN subtypes establish layer/cell type-
and subcellular domain-specific synapses. To achieve this goal, we will perform a series of experiments
using chandelier cells (ChCs), which exclusively innervate axon initial segments (AISs) of layer-specific
pyramidal neurons (PNs). The ChC is known to critically regulate PN spike generation and has been implicated
in schizophrenia and epilepsy. Besides their functional significance, the stereotypy of their synaptic
organization make ChCs an attractive model to study the molecular mechanisms for IN synaptic specificity.
Our preliminary data has shown that: (1) IgSF11 proteins that are known to bind with each other are expressed
in both ChCs and layer-specific target PNs, (2) Gldn proteins that are known to bind to AIS-enriched proteins,
NF186, are preferentially expressed in ChCs, (3) IgSF11 in ChCs plays an essential role in their presynaptic
development, (4) Gldn and NF186 appear to play a role in initiating ChC synapses, and (5) IgSF11 that is free
from the Gldn-NF186 system appears not to induce ChC synapses. Based on our findings, we propose to test
the hypothesis that the layer-specific synaptogenic action and the subcellular domain-specific recognition
mediated through IgSF11 homophilic interactions and Gldn-NF186 interactions, respectively, cooperatively
determine ChC synaptic specificity. We will pursue the following specific aims to test our hypothesis. In Aim 1,
we will determine the role of the IgSF11 homophilic interaction between pre- and postsynaptic neurons in
layer-specific synapse formation by ChCs. In Aim 2, we will determine the role of Gldn and NF186 in ChC
synapse formation on AISs. In Aim 3, we will determine the regulatory role of NF186/Gldn in gating IgSF11
signaling to induce ChC presynaptic boutons at AISs. Upon completion of this study, we will gain not only
important insights into molecular mechanisms for IN wiring but also a clue to developing therapeutic strategies
to functionally repair disordered/damaged brains.

Public health relevance
Project Narrative Cortical inhibitory interneurons (INs) balance and shape excitatory pyramidal neuron (PN) activity in normal cortical circuits and have been implicated in the etiology of brain disorders such as autism, schizophrenia, and epilepsy. However, little is known about the molecular mechanisms shaping synaptic connectivity of local IN circuits. Our studies will provide novel insights into the molecular identities and their interactions that govern synaptic specificity of IN networks and eventually open the floodgate to restoring brain function in disordered/damaged brains.